Translational Biomedical Science Training Grant

Contact PD/PI: VERBALIS, JOSEPH G NRSA-Training-001 (339)
Project Summary/Abstract
This is a renewal application for an institutional training grant in translational biomedical
science (TBS) that is a component of the clinical translational science award application
submitted by Georgetown-Howard Universities Center for Clinical and Translational
Science (GHUCCTS). The TBS program capitalizes on the large diversity of potential
mentorship in clinical and translational research offered through GHUCCTS institutions
including faculty from Georgetown and Howard Universities and the GHUCCTS
partnering institutions, MedStar Health Research Institute and the Washington, DC
Veterans Administration. We request support for 8 trainee positions a year including four
advanced predoctoral students and four postdoctoral fellows in their first or second year
of training. The overall goal of the TBS program is to prepare predoctoral students and
postdoctoral fellows to serve as leaders in forming critical links for advancing the
translation of basic science in to improved outcomes for health, aging and disease. Our
training approach is based on the principle of 'discovery through diversity' and is
accomplished through three specific aims: Aim 1) Provide trainees with a broad
understanding of the diverse types of expertise needed to advance healthcare through
seminars, workshops and course work; Aim 2) Teach trainees how to build effective
interdisciplinary collaborative research programs through training in cultural sensitivity
and leadership skills, team approaches to education at multiple educational levels; and
by providing them with dual-mentored training experiences in preclinical and clinical
research; and, Aim 3) Offer individualized career development opportunities that dove-
tail to discipline-specific training, career stage and career goals.
Page 1550
Project Summary/Abstract
Contact PD/PI: VERBALIS, JOSEPH G NRSA-Training-001 (339)
Narrative
The overall goal of the translational biomedical science (TBS) training program is to
prepare predoctoral students and postdoctoral fellows to serve as leaders in forming
critical links for advancing the translation of basic science in to improved outcomes for
human health. Our training approach is based on the principle of 'discovery through
diversity' and is accomplished through didactic education, workshops, dual mentorship
and experiential learning.
Page 1551

Public health relevance
Project Narrative